Mobile Rehabilitation for Daily Life Participation Post-Stroke

PROJECT SUMMARY/ABSTRACT
The goal of this K01 award is to obtain the mentored training necessary for the principal investigator (PI)
to make a smooth transition to independent investigator in the field of rehabilitation of individuals after stroke.
This proposal builds logically on his previous pre-doctoral and post-doctoral training; however, the protected
time and mentorship associated with this award are necessary to guarantee his independence. Specifically,
this award will support him in pursuing his long-term career goal of becoming an independent research
scientist investigating and promoting optimal function for individuals after stroke, with applied expertise in
innovative mobile technologies. The proposed study has considerable

Public health relevance
PROJECT NARRATIVE Stroke is a leading cause of long-term functional disability in the US, but available assessment methods do not fully capture the complexity of daily function, nor do they address the combination of risk and protective factors that may affect daily function for stroke survivors. Ecological Momentary Assessment (EMA) has proven an efficient, low-cost, and objective measure of function for stroke survivors. Understanding the cognitive, depressed mood, and social support factors leading to functional disability at an individual level will inform the development of new mobile rehabilitation interventions aimed at improving functional independence and maximizing quality of life for stroke survivors.